A sensitivity analysis framework for generalizing randomized clinical trial results in the presence of unmeasured treatment effect modifiers

ABSTRACT
Randomized controlled trials (RCTs) are the gold standard for assessing interventions for preventing and
treating cancer, but their external validity is only guaranteed if the trial participants are a random sample from
the target population. Unfortunately, most cancer-related RCTs use convenience samples, not probability
samples, and differences between the trial sample and the target population are likely to exist. If these
differences are related to the effectiveness of the treatment being studied (“effect modifiers”), trial results will
fail to generalize. While observable differences may be assessed and potentially adjusted for (e.g.,
underrepresentation of certain demographic groups), these differences have been shown to not completely
explain the so-called efficacy-effectiveness gap. We posit that unmeasured differences between who chooses
to participate in an RCT and who does not may be an important contributor to the failure of some trial results to
generalize. In this project, we propose to develop a statistical framework for quantifying the potential impact of
unmeasured differences between the trial sample and the target population on trial results. The resulting
sensitivity analysis will bound the potential bias in the treatment effect estimate when generalizing from the trial
sample to a target population. The methodology will be based on our prior work developing sensitivity analyses
in the areas of survey nonresponse and selection bias which similarly consider the issue of differences
between who is in a study sample and who is not. This work will have broad applicability beyond cancer trials,
as generalizability is a universal concern of randomized trials across application areas.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE Randomized trials are the gold standard for assessing interventions for preventing and treating cancer, but even a well-designed and well-executed trial can fail to replicate outside of the study if characteristics of the trial sample and the target population differ in ways related to the effectiveness of the intervention. This project will develop a novel method of assessing the generalizability of trial results to external populations when factors that are associated with treatment effects are unmeasured in the trial. This work will have broad applicability beyond cancer trials, as generalizability is a universal concern of randomized trials across application areas.